Self-aligning, motion-stabilized ocular imaging for eye care in urgent and emergent care settings

ABSTRACT
This research proposal from a multi-disciplinary team including urgent and emergent care physicians,
ophthalmologists, and biomedical engineers seeks to improve the ability of non-specialty providers to provide
ocular exams at the point of care. Urgent and emergent care settings are frequently the access point of
patients seeking eye care. Standard of care instruments to examine the eye in these non-specialty settings are
notoriously difficult to use, and patients frequently are referred out for later specialty care at added expense in
time and delayed care. To improve the likelihood of diagnostically useful eye examinations in these non-
specialty settings, we will introduce a remote, semi-autonomous eye imaging system capable of retinal optical
coherence tomography (OCT), retinal scanning laser ophthalmoscope (SLO), and anterior segment slit
illuminated imaging that can be used without need for on-site staffing for operation.
These developments have both direct immediate clinical and research applicability by providing the potential to
readily examine patient eyes where the patients already are. In addition, there are future implications as a
platform for remote diagnostic capabilities in other settings where specialty eye care may be limited.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it is expected to improve the ability of non-specialty urgent and emergent care providers to provide patients with eye examinations on site. Leveraging innovative imaging technologies developed by our laboratories and modified specifically to be used without on site personnel, we expect to make modern ocular imaging techniques more readily available where the patients are. This provides the potential to improve eye diagnostics at the point of care in a physically distanced manner.